Administrative Core – Improving Provider Announcement Communication Training (IMPACT)

The Administrative Core will provide overall guidance, administrative support, and fiscal management for the P01 Program Project, “Improving Provider Announcement Communication Training (IMPACT).” Dr. Noel Brewer will be the Administrative Core Lead as well as the Principal Investigator for the Overall Program Project. The Administrative Core will have a central function in establishing linkages between all program elements, ensuring regular communication both within the program and with external organizations, and overseeing the Program Project as a whole and the pilot grant program. The three specific aims of the Administrative Core are as follows. Aim 1. Foster effective collaboration across IMPACT's research projects and cores to consolidate their research activities and products. The Administrative Core will establish an Executive Committee comprised of project and core leads; annually convene the External Advisory Board comprised of stakeholders including health care providers and healthcare system leaders; and coordinate our Annual Retreat. Aim 2. Manage IMPACT's operations and progress toward milestones. The Administrative Core will provide organizational leadership and infrastructure necessary for overseeing research projects and shared core resources; provide administrative support to ensure regulatory compliance of research; oversee fiscal management and reporting; and monitor projects' and cores' progress toward milestones across all phases of research. Aim 3. Administer the Rapid Response Pilot Grant Program. The Pilot Grant Program will fund new and timely pilot studies to address emerging ideas and the evolving needs of the field. Using a comprehensive approach, the Administrative Core will leverage our research projects and cores, collaborative relationships, shared resources, and investigators' expertise to establish capacity that individual research projects could not achieve on their own. The Administrative Core addresses the IMPACT Program Project theme by helping our research projects to build capacity for communication interventions among primary care teams in healthcare systems.

Public health relevance
NARRATIVE – Administrative Core Not applicable.